Renal mechanisms of hypertension in autoimmune disease

The prevalence of hypertension is markedly increased in patients with autoimmune disorders, and growing
evidence links primary hypertension to immunological changes associated with autoimmunity including the
production of autoantibodies (IgG). The underlying mechanisms by which autoimmunity contributes to the
prevalent hypertension in the general population and U.S. active duty military and veterans remains poorly
understood. This proposal will directly advance our understanding of hypertension during autoimmunity, thus
narrowing a knowledge gap that will ultimately lead to improved treatment of hypertension not only for U.S.
military veterans, but also for patients with primary hypertension. We previously established that 1) an
experimental mouse model closely mimics human SLE including the prevalent hypertension with significant
renal immune cell infiltration; 2) mice with SLE have impaired renal vascular function and renal sodium
handling as an underlying factor in development of hypertension; 3) renal production of reactive oxygen
species is increased, and treatment with general antioxidants attenuates the hypertension in mice with SLE; 4)
immunosuppressive and anti-inflammatory treatments protect against the development of hypertension during
SLE in association with reduced renal oxidative stress; and 5) circulating IgG, a critical pathogenic mechanism
of autoimmune diseases, directly contribute to the hypertension in mice with SLE. Taken together, these
studies strongly suggest that immune mediated increases in renal oxidative stress is a fundamental
mechanism leading to the prevalent hypertension during autoimmunity. Despite this evidence, surprisingly little
is understood about the cellular sources of reactive oxygen species in the kidneys, or the intracellular
mechanisms that increase renal oxidative stress during SLE. In a preliminary study, we show that renal
neutrophils are increased in mice with SLE and that these same mice make IgG to myeloperoxidase, an
enzyme essential for the neutrophil oxidative burst and associated with neutrophil extracellular traps (NETs)
that are pathogenically linked to autoimmune disease in humans. In addition, we identified IgG raised against
mitochondrial antigens, and have preliminary data showing that mitochondrial respiration is impaired, along
with increased production of mitochondrial reactive oxygen species. Taken together, these data suggest a
central role for IgG, neutrophils and mitochondrial dysfunction in the pathogenesis of autoimmune mediated
hypertension. This proposal will examine how NETs and IgG act at the cellular level to cause mitochondrial
dysfunction in a feed forward mechanism. We propose that this feed forward mechanism is propagated by IgG
mediated activation of FcγR, and the subsequent activation of the NLRP3 inflammasome. Based on our
preliminary and published data, our central hypothesis is that during SLE, NETs initiate mitochondrial damage
in the kidney that leads to the production of IgG raised to mitochondrial antigens. The autoantibodies bind to
FcγR in the kidney and activate the NLRP3 inflammasome, further impairing mitochondrial function. This sets
up a feed forward mechanism of mitochondrial ROS generation that causes renal vascular dysfunction and
increased sodium reabsorption resulting in increased arterial pressure. Using a clinically relevant experimental
model that closely mimics human SLE, this hypothesis will be tested in the following specific aims (1) To test
the hypothesis that during SLE neutrophils are important mediators of renal mitochondrial dysfunction and
mechanistically contribute to the development of hypertension. (2) To test the hypothesis that during SLE,
circulating IgG promotes impaired mitochondrial function through FcγR mediated activation of the
inflammasome, leading to ROS generation, impaired renal function and hypertension. These experiments will
significantly advance our understanding of the underlying pathology for changes in renal function that cause
hypertension both for patients with SLE and for the general population.

Public health relevance
Despite decades of work, the mechanisms that cause high blood pressure (hypertension), a major health concern for veterans, continue to be elucidated. Immune system activation has been linked to the development of hypertension, and is also directly linked to rheumatic diseases like systemic lupus erythematosus (SLE) that predominantly affect women. Rheumatic disease and are a major health concern for the military, and women represent an increasing demographic among veterans. This proposal will explore how immune system activation during SLE impacts kidney function and leads to hypertension with a focus on understanding a specific immune cell type (neutrophils) and the powerhouse of cells (mitochondria). Examining how the immune system impacts blood pressure during this disease will not only provide new insights for women with SLE, but also will add to the overall understanding of hypertension.